Regulation of enteric motor neurocircuits by enteric glia in health and disease

PROJECT SUMMARY
Experiencing gut inflammation imparts long-lasting effects on the neural control of gut motility that contribute to
persistent gut motility issues in irritable bowel syndrome and inflammatory bowel disease. Intestinal motility is
governed by neural circuits in the enteric nervous system (ENS) and changes in how enteric motility
neurocircuits function play a central role in post-inflammatory gut dysfunction. The underlying mechanisms
remain poorly understood. Enteric glia surround enteric neurons and regulate gut motility through effects on
neuronal excitability and neuroinflammation. The overall goal of this proposal is to define how specialized
interactions between enteric glia and neurons regulate motility and how alterations in those mechanisms
contribute to post-inflammatory gut dysfunction. This proposal tests the central hypothesis that enteric
gliotransmission regulates gut motor function through subtype-specific effects on enteric neurons and that
inflammation provokes a switch in gliotransmission that disrupts neural control of gut motor functions. This dual
hypothesis will be tested in two specific aims that utilize neuron subtype-targeted genetically encoded calcium
indicators and glial chemogenetic actuators to study how glia modulate specific types of enteric neurons, and a
post-inflammatory model of enteric neuroplasticity to study how glia contribute to ENS hyperexcitability
following inflammation. Aim 1 will study the cell- and synapse-specificity of gliotransmission in propulsive
motility neurocircuits by testing the hypothesis that enteric gliotransmission regulates propulsive motility
through subtype-specific effects on enteric neurons. Aim 1.1 will involve cellular imaging experiments that
combine neuron subtype-targeted GCaMP expression with glial cell activation using chemogenetics to test the
hypothesis that enteric gliotransmission preferentially influences interneurons in propulsive motility reflexes.
Aim 1.2 will use the DNBS colitis model to understand how changes to the nature and specificity of
gliotransmission promote ENS hyperactivity following inflammation. Aim 2 will study how glia regulate colonic
motor complex behavior by coordinating excitatory neurons. Aim 2.1 will use calcium imaging experiments in
mice that express GCaMP in cholinergic neurons and chemogenetic actuators in glia to test the hypothesis that
enteric gliotransmission mediated by S100B regulates rhythmic cholinergic neuron activity underlying colonic
motor complexes. Aim 2.2 will test the hypothesis that a failure of this glial regulatory system contributes to
uncoordinated colonic motor complex function following inflammation through effects on neuron and glial
excitability. The results of this study will provide novel insight into glial mechanisms that regulate ENS circuits.
A better understanding of the glial mechanisms that regulate motility will facilitate developing new therapeutics
that modify ENS command of gut motility.

Public health relevance
PROJECT NARRATIVE (RELEVANCE) Experiencing gut inflammation creates long-lasting defects in gut motility through effects on neurons in the intestine that control gut movements. The proposed studies investigate how glial cells that surround these neurons regulate their function and how altered glial regulation contributes to dysmotility following inflammation. A detailed understanding of the role of enteric glia will lead to new therapies to treat GI motility disorders.